Differential risk factors for hepatocellular carcinoma in metabolic dysfunction-associated steatotic liver disease (MASLD) patients of native Hawaiians compared with US whites

Cancer health disparities remain in the US health care system. The incidence rate of liver cancer was 8
times in American Samoans and 2-3 times in Native Hawaiians compared with non-Hispanic whites (NHW)
(https://minorityhealth.hhs.gov/). The underlying reasons for this large variation in liver cancer between Native
Hawaiians/Other Pacific Islanders (NHPI) and NHW are not completely understood. It is generally believed that
lifestyle factors, cultural barriers, and disparate exposures to carcinogens and pathogens may contribute to the
liver cancer disparities. In this supplemental grant application, we propose to expand our original cohort of
high-risk individuals for liver cancer in Western Pennsylvania, most of whom are NHW, to recruit and establish
a cohort of NHPI individuals at high risk for liver cancer, through an inter-institutional collaboration.
The liver is an organ that is constantly exposed to a wide range of immunomodulators, environmental
toxins, and gut microbial metabolites through the portal vein. To ensure upkeep of immune tolerance to self
and foreign antigens, the liver has a unique immunotolerance mechanism. Heightened immunotolerance or
immune permissive microenvironment may create a setting with compromised immunosurveillance that
promotes the tumor development and growth in the liver. The gut microbiota can produce large quantities of
metabolites such as secondary bile acids that have genotoxic and tumor-promoting effect. The gut dysbiosis
due to obesity and other metabolic diseases, which are underlying conditions for non-alcoholic fatty liver, alters
the metabolism, synthesis, and transport of bile acids, resulting in the change of bile acid pool size and
characteristics. The altered bile acids profile can elicit inflammation and cause liver injury, leading to fibrosis
and cirrhosis, and eventually hepatocellular carcinoma. We propose prospectively enroll at NHPI patients with
non-alcoholic fatty liver disease. All study participants will be longitudinally followed up for the occurrence of
liver cancer and end-stage liver disease. The specific aims are to determine if immunosuppressive cytokines,
altered bile acid profiles, and the gut dysbiosis have significant impact on the risk of developing liver cancer
and end-stage liver disease. Furthermore, we will integrate these data with the similar study in NHW in
Western Pennsylvania and assess the differential associations for immunosuppressive cytokines, altered bile
acid profiles, and the gut dysbiosis with liver cancer risk between the two study cohorts. The findings, if prove
our hypotheses, will provide much needed scientific evidence for our understanding the liver cancer disparity
between NHPI and NHW populations. These finding will help develop effective and unique strategy for
management and surveillance for NHPI individuals at high risk for developing liver cancer and other end-stage
liver disease.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma incidence has been increasing in the past several decades in the United States due to increasing prevalence of metabolic-dysfunction associated steatotic liver disease. Native Hawaiians and other Pacicific Islanders have high risk of metabolic-dysfunction associated steatic liver disease and hepatocellular carcinoma. The adminstrative supplement will investigate the different risk profiles for Native Hawaiians/other Pacific Islanders.